Cellular, Biochemical and Molecular Sciences Training Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
T32 GM137793 Vanderbilt CBMS Training Program
The Cellular, Biochemical, and Molecular Sciences (CBMS) T32 Training Program at Vanderbilt University provides a unique educational and training experience for Vanderbilt graduate students spanning multiple departments and disciplines in the School of Medicine and the College of Arts and Science. The mission and objectives are to train the next generation of scientific leaders in critical thinking, experimental design, and communication/teamwork skills necessary for productive careers in modern biomedical sciences. Laboratory training and cutting-edge research constitute the core of the program, complemented by structured didactic training in each discipline, as well as ongoing mentoring, training in Responsible Conduct in Research, Rigor and Reproducibility, career counseling, leadership, and communication skills.
The CBMS Training Program serves a unique role in interdisciplinary graduate training at Vanderbilt by embracing a large preceptor list that spans 11 different departments and programs. We emphasize broad-based, basic, interdisciplinary research encompassing labs that study a range of topics, complementing other training programs at Vanderbilt that are frequently more discipline-specific. Our program promotes intellectual exchange within the biomedical community at the intra- and inter-laboratory levels. We conduct the only university-wide, weekly journal club providing high level scientific presentations across disparate fields from leading researchers in each area. Trainees also participate in dedicated sessions providing opportunities for oral research presentations, training in responsible conduct in research, rigor and reproducibility, career training, and biosafety.
Since no one knows with certainty which areas of modern biomedical science will be required in the coming years, it is essential to provide a breadth of training and interdisciplinary exposure to position the next generation of researchers and leaders so they are well positioned to capitalize on new findings, employ critical thinking skills, and be poised for success in traditional and unforeseen areas.

Public health relevance
The Cellular, Biochemical, and Molecular Sciences (CBMS) Training Program provides a highly enriching, rigorous, interdisciplinary environment to train the next generation of scientists to identify and attack critical, basic-science questions in medicine and biology. Our established cadre of preceptors and programmatic activities foster trainee development leading to new approaches and technologies to address critical challenges at the cutting edge of biomedical science.